Translating Molecular Diagnostics for Cervical Cancer Prevention into Practice

ABSTRACT/SUMMARY
Cervical cancer, entirely preventable, remains the 4th most common cause of cancer incidence and mortality in
women, with over 12 million new cases predicted in the next 50 years without sustained scale-up of HPV
vaccination and cervical screening. More than 80% of the disease burden occurs in low- and middle-income
countries (LMICs), reflecting inequitable availability and adoption of effective preventive strategies.
Unfortunately, sustainable implementation of cervical screening and management for cervical cancer
prevention has been elusive in LMICs, reflecting challenges of implementing complex health interventions in
complex adaptive health systems. In the parent study, using participatory systems thinking as our `grand
theory', we integrated various implementation science frameworks into the Integrative Systems Praxis for
Implementation Research (INSPIRE) to guide multilevel stakeholders through four phases of an iterative cycle
of implementation activities, enabling stakeholder-engaged adaptation of complex health technologies to local
health system contexts. In Aim 1 of the continuation of this project, we will conduct a realist evaluation of
stakeholders involved in the INSPIRE research, to gain an understanding of the mechanisms through which
the INSPIRE activities led to successful adoption and rapid scale-up of HPV-based testing in a large health
network in the Peruvian Amazon. In Aim 2 we propose to translate the INSPIRE research methodology into a
generalizable implementation strategy (Aim 2) – “Adaptation, Scale-Up, Sustainability: Implementation by
Systems Thinking” (ASSIST) - and develop an implementation toolkit to enable stakeholder-engaged
implementation planning and context adaptation. In Aim 3, we will leverage the planned scale-up of HPV
implementation plans from the Peruvian Ministry of Health to test the ASSIST implementation strategy for
impact on screening coverage and management using an interrupted time series design, using the extended
RE-AIM evaluation framework. In parallel, we will conduct a qualitative comparative case study to enable
understanding of context-dependent mediators and modifiers to the success of the ASSIST implementation
strategy (Aim 3). The realist evaluations are designed to examine `what works for whom, in what
circumstances, in what respects, and how' vs assuming that one size fits all. Ultimately, meeting our proposal
aims will advance public health, by providing a broadly generalizable process and toolkit for context-adaption
of HPV-based screening and management that can be used in LMICs, and implementation science, by helping
to reduce the evidence gap in implementation science for approaching scale-up and sustainability of complex
health interventions in diverse contexts.

Public health relevance
PROJECT NARRATIVE Reducing the global disparities in cervical cancer – which is an entirely preventable disease – requires scale- up of available preventive interventions such as HPV vaccination and screening. Biomedical research has successfully developed technologies required to meet this demand; now we must complement this success with development of processes and tools to help countries adopt and integrate these prevention strategies into their routine public health services. Our project builds on a successful application of stakeholder-engaged systems thinking by developing the ASSIST (Adaptation, ScaleUp, Sustainability: Implementation by Systems Thinking) implementation strategy and toolkit, designed to enable countries to adapt and plan for HPV-based screening according to their own context, resources, preferences, and values.